HOST-PATHOGEN INTERACTION CORE

PROJECT SUMMARY (See instructions): The mission of the Host-Pathogen Interaction Core (HPIC) is to advance basic science, as well as translational and discovery studies relevant to lung disease. A central service of this Core is to provide expertise using a co-culture platform of bacterial biofilms on human airway cells developed at the Geisel School of Medicine at Dartmouth. This Core also provides a range of airway cell lines, as well as primary human airway epithelial cells from CF and non-CF donors, to support studies assessing host-pathogen interactions of relevance to the lung. This Core facilitates ongoing studies of COBRE Lung Biology Center (LBC) investigators and the pilot studies supported via this COBRE 111 application. The notable accomplishments of the HPIC include: 1) Development of a novel co-culture model system; 2) Assistance with a wide range of host-pathogen interaction studies by providing expertise in cell culture, siRNA and other molecular techniques, and electrophysiology studies; and 3) Coordinating with industry to develop new therapeutics aimed at chronic infections of the lung. The HPIC was launched in 2010 in response to a growing need by COBRE LBC investigators for support in crosscutting studies at the interface of bacterial pathogenesis and the host airway. We leveraged a set of earlier findings from the Stanton and O'Toole labs, in particular the study of bacterial biofilms on airway epithelial cells and host-pathogen interactions, to build a critical set of novel capabilities that have been used extensively by LBC investigators since the inception of this core. The HPIC was developed to meet the unique research needs of LBC investigators and received approval and strong backing from the External Advisory Committee, who deemed it critical to meet the needs of the evolving LBC. This Core is directed by George OToole, Ph.D., Professor of Microbiology and Immunology. Dr. OToole has over 20 years of experience in bacterial systems, and since 2000 has worked closely with Dr. Bruce Stanton, COBRE Director and PI, on a variety of projects that directly resulted in the development of the central capabilities of this Core.

Public health relevance
RELEVANCE (See instructions): Infectious respiratory diseases are the third leading cause of death in the U.S. The studies described in this application will lead to a better understanding of how opportunistic pathogens, including Pseudomonas aeruginosa, cause chronic respiratory infections, and to new drugs / therapies to treat infectious respiratory disease.